Advanced genome and transcriptome analysis using long-read sequencing technologies

Project Summary
As the advancement of long-read sequencing technologies and cutting-edge algorithms, haplotype-
resolved telomere-to-telomere (T2T) genome assemblies have almost become available. With more complete
genomes and whole-genome long-read sequencing data becoming available, there is an urgent need for
comprehensive and personalized analysis of both genomes and transcriptomes. For example, long reads
facilitate the discovery of an unprecedented level of structural variations. However, the detailed genome
architecture, evolution, and function of multiallelic copy number variations (mCNVs) are unknown, as are
nuclear mitochondrial DNA segments (NUMTs). In addition, pan-genome and individualized genome
annotation are not yet available, nor are complex rearrangements in the transcriptome, such as V(D)J
recombination and gene fusions. Without a comprehensive investigation of individual genomes and
transcriptomes, we may miss important information residing at the genome or transcriptome level that may
account for various phenotypes and associated diseases. The long-term goal of the laboratory is to
comprehensively characterize all forms of genomic and transcriptomic variations and understand their
functional consequences and formation mechanisms. While the ESI MIRA has enabled the Principal
Investigator to establish a sustainable research program in genomics and bioinformatics with a focus on long-
read genomic algorithm development and data analysis, the primary goals for the MIRA Renewal over the next
five years include expanding the program to concentrate on both genomic and transcriptomic algorithm
development for long-read sequencing, as well as advancing the analysis of sequencing data. The proposed
work is innovative as it leverages long-read sequencing technologies combined with advanced bioinformatics
tools to enhance the analysis of mCNVs and other genomic variants, offering significant improvements in our
understanding of human genome evolution and the potential for novel clinical applications in areas like cancer
genomics and precision medicine. The proposed research is significant because it pioneers the application of
long-read sequencing to provide a deeper and more accurate understanding of complex genomic and
transcriptomic structures, which are critical for unraveling the intricate relationships between genetic variations
and phenotypic outcomes in human health and disease.

Public health relevance
The proposed research is relevant to public health because it aims to unravel complex genomic structures and variations such as mCNVs and NUMTs, which have profound implications on human health, disease susceptibility, and treatment response variability. Understanding these genetic variations through long-read sequencing technologies enhances our capacity to detect, diagnose, and potentially correct genetic disorders more efficiently, directly impacting the management and prevention of diseases. This approach is relevant to the part of NIH’s mission that pertains to seeking fundamental knowledge that will enhance health, reduce illness, and promote a deeper understanding of the genetic basis of human health and diseases.